Skeletal Muscle Remodeling and Intramuscular Adipose Tissue following Traumatic Knee Injury

PROJECT ABSTRACT
This is an application for the NIAMS K01 Mentored Research Scientist Development award for Dr. Stephan
Bodkin, an Assistant Professor in the Department of Physical Therapy and Athletic Training in the College of
Health at the University of Utah. Dr. Bodkin is establishing himself as an emerging leader in sports medicine
research, specifically in advancing clinical decision making in returning patients to activity following traumatic
joint injuries. This K01 award will provide Dr. Bodkin the support necessary to accomplish the following career
development goals: 1) Obtain training in molecular techniques of skeletal muscle cellular remodeling, especially
relating to the quantification of intramyocellular lipids and fibrosis, 2) Expand my knowledge in age-related
changes to skeletal muscle and cartilage degradation within the lifespan of osteoarthritis diagnosis, 3) Develop
expertise needed for clinical interpretation of MRI as it relates to skeletal muscle and cartilage, and 4) Strengthen
leadership and research skills required to conduct clinical trials successfully. To achieve these goals, Dr. Bodkin
has assembled a mentoring team comprised of a Scientific Mentor, Dr. Micah Drummond, a translational
researcher experienced in biological mechanisms of aging skeletal muscle atrophy and regrowth, a Career
Mentor, Dr. Jennifer Majersik, a clinical neurologist with a proven track record of mentoring junior faculty
members, and 5 advisors with expertise in aging medicine (Dr. Mark Supiano), biostatistical design and analysis
(Mr. Greg Stoddard), clinical imaging (Dr. Glenn Morrell), orthopedic surgery (Dr. Travis Maak), and skeletal
muscle function following joint injury (Dr. Lindsey Lepley).
Dr. Bodkin’s work has well documented skeletal muscle weakness following anterior cruciate ligament
reconstruction (ACLR) and the inability to restore strength despite undergoing traditional post-operative
rehabilitation. This work and others suggest potential physiological contributors to skeletal muscle weakness
following ACLR. Based on recent evidence, Dr. Bodkin’s central hypothesis is that ACL injury and reconstruction
promotes the infiltration and development of muscle adiposity which thus impairs muscle strength. He will test
this hypothesis by serially quantifying intramuscular adipose tissue (IMAT) and intramyocellular lipids (IMCL) in
patients undergoing ACLR and relating measures of muscle adiposity to strength. These outcomes will be
collected in young and middle-aged adults, exploring potential interactions of age and traumatic injury on skeletal
muscle remodeling. By pursuing the following specific aims, the applicant will test his hypothesis and gather data
for a subsequent R01 application to investigate rehabilitation interventions on skeletal muscle biology following
traumatic joint injuries. Specific Aim 1 will determine the influence of ACLR on quadriceps adiposity by
quantifying IMAT and IMCL pre-ACLR, 2 weeks post-ACLR, and 3 months post-ACLR. Specific Aim 2 will
determine the relationships between IMAT and IMCL to quadriceps muscle strength 3 months post-ACLR.
Specific Aim 3 will evaluate the difference in age related changes in muscle adiposity following knee surgery
by comparing serial changes in IMAT and IMCL post-ACLR between young and middle-aged adults.
The proposed research is significant because traditional strength training may fail to overcome the skeletal
muscle weakness that presents following ACLR. Investigations into physiologic contributors to skeletal muscle
weakness are a priority research area to personalize healthcare and aligns with the NIAMS strategic plan, “to
turn discovery into health”. My proposed study will determine acute changes in skeletal muscle remodeling
following ACLR and establish relationships between cellular changes and muscle strength.

Public health relevance
PROJECT NARRATIVE Anterior cruciate ligament injury promotes chronic skeletal muscle weakness and leads to early diagnosis of osteoarthritis. This project seeks to investigate physiologic contributors to skeletal muscle weakness, such as intramuscular adipose tissue, and how it is influenced with age. This will promote impairment-based treatments and rehabilitation to restore skeletal muscle function following injury.